Pathology Core

In FY23, Due to the pandemic, the Pathology Facility was served less users compared with previous years. We have provide histopathology requests for more than 10 users/Lab from NHLBI and from 3 Non-NHLBI users.

We have added to our repertoire of procedures based on suggestions by users of ways to optimize their research. The key factor for the Core is adaptability on response to users needs.

a) The Facility offers consultation in cardiac and pulmonary pathology.
b) We provide working bench training for Core users.
c) Core collaborates with PI to develop new techniques.
d) We have solicited feedback from the Steering Committee and potential users to better understand their needs.

The pathology Facility has contributed 4 publications in FY2023.

Our Facility not only provides service for NHLBI DIR laboratories, we are also open to NIH campus wide for their histology needs. For FY23, we have users from 3 different institutes other than NHLBI, who sent requests to us because of customer services, quality, convenience and low costs.